Administrative Core

Summary (Administrative Core)
The Program Project “Convergent Epigenetic Control of Diverse Neuroendocrine Cancers” has 3 Projects
and one Shared Resource Core. The Administrative Core will be responsible for the smooth logistics of this
Program. The three Projects are led by six faculty-rank Leaders that rely on extensive collaborations that will
be coordinated by the Administrative Core. The Administrative Core will provide significant and effective
administrative support to achieve the scientific objectives of the program, namely, to enhance our
understanding of neuroendocrine cancers arising from prostate, lung, intestine, and skin tissues. To
accomplish these goals, the Administrative Core has three Specific Aims.
Specific Aim 1: Provide leadership and administrative expertise to enable a Program focused on
Neuroendocrine Cancers. The Administrative Core is responsible for the financial accounting for
the Program, Projects, and Cores and deals with the research administration offices of the participating
institutions on financial and protocol issues
Specific Aim 2: To facilitate collegiality, collaboration, coordination, and communication across the
Program. The Administrative Core will monitor the progress of the Projects and the Epigenomics Core,
arrange for the Monthly Program Lab Meeting, Quarterly Meeting with all Project and Epigenomics co-Leaders
and the Epigenomics Core Leaders, and an Annual Retreat for the entire Program including members of the
External Advisory Board.
Specific Aim 3: To further the training and development of scientists. The Administrative Core will
promote the training of post-doctoral fellows, graduate students, and other laboratory personnel.
The Program is far more than 3 individual Projects, as there are close and extensive collaborations among
the Projects and with the Epigenomics Core. The Administrative Core ensures that these collaborations are
synergistic and collegial, and that they promote efficiency in the use of limited resources, including use of the
Epigenomics Core.

Public health relevance
Narrative (Administrative Core) The Program Project “Convergent Epigenetic Control of Diverse Neuroendocrine Cancers” has 3 Projects and one Shared Resource Core. The Administrative Core will be responsible for the smooth logistics of this Program. The Administrative Core will provide significant and effective administrative support to achieve the scientific objectives of the program, namely, to enhance our understanding of neuroendocrine cancers arising from prostate, lung, intestine, and skin tissues.